Bio statistics Core

PROJECT SUMMARY
The Biostatistics and Computational Biology Core will provide comprehensive statistical, bioinformatics and
computational biology support for all three projects and for the Preclinical Modeling and the Pathology Cores.
The Core Leader, Dr. Nabihah Tayob, and other members of the Core team will bring in the statistical and
computational biology expertise required for experimental design, pre-clinical and clinical studies, as well as data
collection, management, integration, and quality control. The core has identified key areas where the members
of the core will collaborate with project investigators and core leaders to ensure integrated and comprehensive
biostatistical support to the entire P01 program. The primary role of the Biostatistics and Computational Biology
Core is to provide biostatistics and computational biology expertise for the design, conduct, monitoring, analysis,
and reporting of laboratory, animal, translational, clinical studies and including associated correlative studies.
The Biostatistics and Computational Biology Core will also provide input on data collection, management and
integration and assist investigators in coordinating laboratory results with outcomes from clinical studies or
clinical/translational research databases and work with investigators to develop new statistical methods to
address problems arising in endometrial cancer research for which no standard methodologies are available.

Public health relevance
PROJECT NARRATIVE The Biostatistics and Computational Biology Core will provide statistical, bioinformatic and computational consultation and in-depth collaboration to the P01 research program in the areas of planning, design, conduct, analysis, and reporting of laboratory experiments, and clinical trials. Having a dedicated group of biostatisticians and computational biologists with expertise in therapeutic cancer clinical trials will ensure the best possible designed studies to answer scientific questions of interest related to targeting replication stress in endometrial cancer.